Technology-Enabled Therapy for Elders with Mild Cognitive Impairment and Co-morbid Insomnia

Abstract Mild cognitive impairment (MCI) is often viewed as a transitional stage between normal aging and early stage of Alzheimer’s disease and related dementia. MCI affects up to 20% of the population of older adults, and sleep disturbances have been identified as one of the core neuropsychiatric problems in MCI. Sleep disturbances are associated with a range of negative outcomes for persons with MCI, including worsening cognitive function, physical function, depression, and fatigue, which can all lead to functional impairments that greatly reduce quality of life. One of the most common sleep disturbances in persons with MCI is insomnia, with a prevalence of 44%. While non-pharmacological treatments, especially in-person cognitive behavioral therapy for insomnia (CBTI), have demonstrated clinical efficacy in improving sleep and preserving cognitive function in the general population of older adults, there have been few studies focused on adapting CBTI for older adults with MCI. The goal of this SBIR Phase I is to develop and test a provider-supported, technology-enabled system to adapt and deliver evidence-based CBTI to persons with MCI and co-morbid insomnia, with the support of health providers. The proposed intervention combines internet/mobile-based delivery and smart messaging prompts as reminders to compensate for cognitive processes that can be impaired in MCI. Specific aims for this Phase I include: (1) Develop a technology-enabled system to deliver CBTI for older adults with MCI; (2) Conduct formative evaluations with persons with MCI to refine smart messaging prompts and test usability of the patient software platform, and cognitive interviews with providers to assess feasibility of implementing the intervention in the clinical setting; and (3) Conduct a six-week pilot randomized controlled trial to assess preliminary effectiveness and feasibility of the CBTI intervention. We hypothesize that participants in the CBTI intervention group will demonstrate a significant improvement in quality of sleep (both subjective and objective), and an improvement in cognitive and physical functioning, compared to those in the control group. Data collected in Phase I will be used to determine the sample size necessary for an adequately powered Phase II randomized trial. If successful, this product will contribute to the adoption and dissemination of a low-cost, multi-technology enabled CBTI intervention to reduce sleep disturbances, and improve cognitive and physical function among persons with MCI. A successful Phase II study will result in a technology-enabled program that can benefit multiple types of provider organizations (mental health clinics, primary care clinics, and geriatric clinics) serving large numbers of older adults with MCI, thus having significant commercial potential.

Public health relevance
Narrative More than 5 million people in the United States suffer from mild cognitive impairment (MCI), with over 44% of them experiencing insomnia. Given the negative outcomes associated with MCI and co-morbid insomnia, there is strong interest in developing non-pharmacological treatments for improving sleep in this population of older adults. The proposed project provides a technology-enabled system that is designed to adapt cognitive behavioral therapy for insomnia (CBTI) for older adults with MCI. Combining emerging innovative technologies with evidence-based practice, the proposed CBTI intervention system has the potential to be deployed by multiple provider organizations, including mental health clinics, primary care clinics, geriatric clinics, and home care agencies, potentially benefiting millions of older adults in the U.S. who have MCI and co-morbid sleep problems.